GROWTH FACTOR RECEPTORS AND MITOGENIC PATHWAYS IN TRANSFORMATION

1. The characterization of novel epidermal growth factor receptor (EGFR) substrates, isolated by an expression cloning system was continued. the expression cloning method was described in a previous annual report. Analysis was focused on novel substrates: eps7, eps8, eps15 and eps27. 2. Analysis of the structure/function relationships of EGFR and gp185erbB-2 was also continued, focusing on the role of several domains in mediating receptor internalization. Results indicate that the introcytoplasm's domain of gp185erbB-2 does not possess the molecular signals necessary for rapid internalization, thus dictating a slow rate of removal of this receptor from the cell surface.